Liver-Dependent Lung Remodeling and Pneumonia Susceptibility During Endotoxemia

Project Summary/Abstract
Pneumonia is the leading global cause of infectious disease deaths and contributes to one of the greatest
disease burdens worldwide. It is also the leading cause of sepsis, which in turn predisposes patients to
secondary infections in the lungs and elsewhere. Indeed, patients with sepsis, trauma, or extra-pulmonary
complications are exquisitely vulnerable to hospital-acquired pneumonias. Both diseases are growing public
health concerns with limited treatments. Due to the integrated nature of pneumonia and sepsis, understanding
intra- and extra-pulmonary pathways controlling pneumonia susceptibility in the wake of systemic inflammation
or injury may reveal protective signaling hubs for targeted interventions. The hepatic acute phase response
(APR), activated by both pneumonia and sepsis, is a coordinated response resulting in numerous blood protein
changes that correlate with disease severity and modulate host outcome, albeit in ways that remain somewhat
speculative. We have shown that a robust APR during pneumonia is coordinated by liver activation of the
transcription factors STAT3 and RelA, and when one or both of these factors are eliminated, the APR is diminished
or completely ablated, respectively. In an earlier study, we modeled the conditions of pneumonia susceptibility
during sepsis/systemic inflammation by pre-challenging mice with endotoxemia prior to an intratracheal instillation
of bacteria. These studies revealed substantially worsened pneumonia outcomes in mice lacking hepatocyte
STAT3 (hepSTAT3-/-) compared to littermate controls under the same conditions. While mechanisms of liver-
derived protection remain unclear, our prior and preliminary results together suggest the involvement of both
cellular and innate humoral changes in the immune landscape of the lung. Such changes include airspace
macrophage function as well as liver dependent remodeling of the lung transcriptome and airspace proteome. The
latter corresponds with reduced hepatic synthesis and delivery of coagulation proteins to the alveolar compartment
of hepSTAT3-/- mice. Based on these findings, we propose the central hypothesis that STAT3-dependent liver
activation limits pneumonia susceptibility by reprogramming lung macrophages and dispatching coagulation
proteins to infected airspaces. Aim 1 is designed to test the hypothesis that STAT3-dependent liver-activity
remodels lung macrophages during endotoxemia followed by pneumonia, whereas the goal of aim 2 is to test the
hypothesis that liver-derived coagulation proteins fortifies intrapulmonary bacterial killing and improves pneumonia
outcome. These studies will provide important insights regarding the biological pathways connecting liver
activation and pneumonia susceptibility, possibly revealing targetable clinical interventions for vulnerable patient
populations.

Public health relevance
Project Narrative Pneumonia is the leading cause of infectious disease deaths and the foremost cause of sepsis, which predisposes patients to secondary infections such as hospital-acquired pneumonias. Our proposed studies will investigate intrapulmonary immunity reliant on hepatic STAT3 activity, in order to determine targets for clinical intervention in septic patients with or at risk for pneumonia.